Video intervention to improve dementia literacy and goal of care conversations for Black Americans

PROJECT SUMMARY
Danetta Sloan is an Assistant Scientist, in the Department of Health, Behavior and Society with
education and professional experience as a homecare hospice Social Worker, addressing the needs of
patients and families experiencing end stage Alzheimer’s disease. Her long-term goal is to become a leader in
community-based research to develop, translate, and implement evidenced-based, real world interventions to
reduce inequities in dementia care and access for Aging Black Americans. This award will ensure Dr. Sloan
has the knowledge, skills, and experience to develop, implement and test interventions that build individual and
community capacity to improve early diagnosis, access and quality of care to Black Americans. Dr. Sloan has
convened an outstanding mentorship team with expertise to help develop her career development and provide
training in the relevant research methods to adapt, design cultural appropriate, communication skill building
intervention, to implement and test in the Black Faith community. Despite the growth in dementia information
and dissemination, Black American communities still experience late diagnosis, and suboptimal care, engaging
with dementia care providers later in the disease without adequate knowledge to participate in goal of care
conversations.
With no cure for Alzheimer’s Disease Related Dementias (ADRD), morbidity and mortality remain high
and Black Americans are disproportionately impacted and more likely to have ADRD and be unaware. This
proposal addresses goals of the National Plan to Address Alzheimer’s Disease to 1) optimize care quality and
efficiency and 2) enhance public awareness and engagement. This proposal will equip individuals with skills to
identify signs and symptoms, (increase health literacy in dementia) and goal of care communication training
pre-clinical diagnosis. The outcome of the intervention in Aim 3, will afford those who experience dementia the
opportunity to self-advocate, participate in research, and engage in quality of life decision-making and advance
care planning. Feasibility, acceptability, comprehension and satisfaction, with the intervention and self-efficacy
to engage in a goal of care conversation will be assessed.

Public health relevance
PROJECT NARRATIVE Timely diagnosis of dementia remains a challenge for Black American populations contributing to high prevalence of moderate to severe Alzheimer’s. This proposal will adapt and implement an intervention to increase dementia literacy and provide pre-care setting skills training in goals of care conversations.